OR2H1 is an effective target for CAR T cells in human epithelial tumors

ABSTRACT
Identifying accessible tumor antigens that are not expressed in vital organs would allow genetic
engineering of CAR T cells to avoid dysfunction at tumor beds. We have identified an olfactory receptor (OR)
expressed in a variety of human tumors, ranging from ~70% of intrahepatic cholangiocarcinomas and 39% of
prostate cancers, to ~10% of NSCLCs, and generated CAR T cells that specifically target its extracellular domain.
The long-term goal of these studies is to translate these CAR T cells. Here, we will advance the preclinical work
needed to apply for IND approval for a first-in-human clinical trial conducted at Moffitt, using OR2H1 CAR T cells
generated in our Cell Therapy Facility under GMP conditions. Our central hypothesis is that genetically
engineered OR2H1 CAR T cells can effectively control the progression of established tumors of different
histologies, without the unacceptable on-target, off-tumor effects of other targets expressed in vital tissues.
In Specific Aim 1, we will demonstrate the effectiveness and specificity of targeting OR2H1+ PDX with
CAR T cells in vivo. These studies will support a rationale for subsequent IND approval for OR2H1 CAR T cell
administration in patients with tumors expressing OR2H1 at variable levels.
In Specific Aim 2, we will define the superiority of XBP1-ablated OR2H1 CAR T cells. These studies will
support a rationale for genetic engineering of OR2H1 CAR T cells, to empower them to resist metabolic
restrictions and inhibitory signals at tumor beds.
In Specific Aim 3, we will optimize a method to identify eligible patients for OR2H1 CAR T cell targeting.
Our work could exert a profound effect in the field by supporting a first-in-human clinical trial using OR2H1-
targeted CAR T cells against a variety of solid human tumors, which could have significant benefits in a broad
range of cancer patients, with limited or negligible toxicity.

Public health relevance
PROJECT NARRATIVE Although immunotherapy has revolutionized the management of cancer patients, most tumors remain poorly responsive to existing immunotherapies. The proposed studies will define the potential of a new CAR T cell formulation that could be implemented against multiple human malignancies. These studies will support novel clinical trials, designed to overcome the hitherto insurmountable challenge of controlling many epithelial malignancies using cellular therapies.